CTSA R25 Program at University of Utah: Biomedical Research Inclusion & Diversity to Grow Excellence in science Undergraduate Program for HBCUs (BRIDGE UP–HBCU)

PROJECT SUMMARY
The mission of the Biomedical Research Inclusion & Diversity to Grow Excellence in Science – Undergraduate
Program for Historically Black Colleges and Universities (BRIDGE UP-HBCU) is to build a translational
research workforce reflecting the talent pool of our diverse population by increasing the pool of talented Black
applicants for PhD and MD/PhD programs. This is especially important in the domain of translational science
and research. In fact, Black Americans have increased prevalence of diabetes and cardiovascular disease, are
overly represented in the end stage renal disease populations, and have poorer outcomes for most cancers.
These stark health disparities demonstrate the key need for inclusion of Black biomedical scientists in all
domains of translational research and clinical care, since data support that racial concordance improves
patient outcomes and that diverse research teams foster innovation. The University of Utah CTSI is committed
to fortifying, sustaining and amplifying the STEM pipeline that trains and launches a diverse translational
research workforce. BRIDGE UP-HBCU will specifically address the leaks in the pipeline from undergraduate
to doctoral training of Black and other underrepresented scientists. BRIDGE UP-HBCU will recruit students
with an interest in translational research from partnership relationships with HBCUs, while expanding these
relationships to additional HBCUs. These students demonstrate a strong drive for doctoral research and
physician scientist research tracks and will benefit from exposure to the translational science spectrum,
additional research-intensive training experiences and professional development, enhancing both their
successful transition to top-tier doctoral and professional programs, as well as their long-term retention in the
translational research and science tracks. In order to accomplish these goals, BRIDGE UP-HBCU will provide
key proposed activities that include (1) holistic, culturally competent career-long mentor networks (2)
experiences to undertake hypothesis-driven research; (3) scientific and professional skill development
workshops and activities that hone strong oral and written communication skills, enhances their self-confidence
and authentic scientific identity, and instills successful strategies for applying to graduate school. Building on
institutional momentum and infrastructure at the University of Utah that is dedicated to supporting STEM
equity, diversity and inclusion, BRIDGE UP-HBCU will fortify its trainees’ critical thinking and research
experience, and develop a resilient mindset to persist in high-quality graduate programs and beyond. With
these additional skills, BRIDGE UP-HBCU graduates will be prepared for leadership and mentorship roles in
translational research career tracks.

Public health relevance
PROJECT NARRATIVE A national challenge in the biomedical sciences, and especially translational science/research, is recruiting, training, and retaining the most diverse scientific talent pool possible. At the UU CTSI, we are poised to tackle this challenge by leveraging recent successes at the UU in recruiting underrepresented students to our graduate programs and redoubling our efforts to develop targeted training and pipeline programs for underrepresented students to strengthen our applicant pool for translational science-related graduate programs. We will expand the Biomedical Research Inclusion & Diversity to Grow Excellence in Science – Undergraduate Program for Historically Black Colleges and Universities (HBCUs), and solidify key relationships with our local community and HBCUs to foster an inclusive, research-intensive environment where underrepresented scientists can flourish and attain their goal of admission to top-notch graduate training programs.